Blocking type I interferon signaling to reverse T cell exhaustion and control HIV-1 reservoirs

PROJECT SUMMARY
The long-term goal of this new project is to elucidate the mechanism of pDC/IFN-induced immune
suppression during persistent HIV infection, and develop novel strategy of pDC/IFN-I blockade to control HIV
reservoirs. I postulate that the HIV-activated pDC/IFN-I axis depletes and impairs anti-HIV T cells to maintain HIV-
1 persistence. Thus transient pDC/IFN-I interruption will provide a novel approach of immune recovery in cART-
treated HIV-1 patients and improved control of viral rebound after cART cessation. In addition, restoring human
immunity by transient pDC/IFN-I interruption prior to therapeutic vaccination will also enhance vaccine efficacy to
control HIV-1 reservoirs.
This project is proposed based on several recent findings from the multiple PIs’ labs in HIV-infected
humanized mice and in SIV-infected NHP. (i) Although pDC/IFN-I is critical to suppress acute HIV-1 replication
and to prime anti-HIV T cells, depletion of pDC during persistent HIV-1 infection reverses HIV-1 diseases in
humanized mice, even in the presence of elevated HIV-1 replication, and rescued anti-HIV T cells. (ii) blocking
IFNAR with an mAb also reversed HIV diseases in HIV infected humanized mice, “phenocopying” pDC depletion.
(iii) In HIV-infected hu-mice under cART, IFNAR blockade or pDC depletion reversed inflammation, rescued
human T cells and reduced HIV+ reservoir cells, via CD8-dependent mechanism. (iv) CD40-targeting vaccines
induced T cell responses and reduced HIV reservoirs in humanized mice and SIV reservoirs in NHP. We
hypothesize that IFN-I from persistently activated pDC contribute to HIV-induced aberrant inflammation, impaired
immunity and HIV-1 persistence. The project will elucidate mechanisms of pDC/IFN-induced immune suppression
(Aim 1) and functionally define the role of pDC/IFN-I in SIV persistence during cART (Aim 2). We will also explore
the idea of blocking pDC/IFNAR prior to therapeutic vaccination under cART to control or cure HIV-1 or SIV
reservoirs in humanized mice or in NHP models (Aim 3). Findings from the proposed aims will not only elucidate
novel mechanisms of pDC/IFN-I in impairing host immunity, the IFNAR blocking bAb and pDC depleting dAb will
also be developed into novel therapeutics to 1) resolve aberrant inflammation and recover immune activity in HIV-
1 patients under cART and 2) enhance therapeutic vaccination to achieve control of HIV rebound after cART
interruption (functional cure).

Public health relevance
PROJECT NARRATIVE: This project is to study the HIV-pDC/IFN axis in immune suppression during persistent HIV infection, define the role of pDC/IFN-I in HIV/SIV reservoir persistence during cART and develop novel therapeutic approach to controlling the HIV reservoir. Findings from the proposed project will not only elucidate novel mechanisms of pDC/IFN-I in impairing host immunity, the IFNAR blocking and pDC depleting antibodies will also be developed into novel therapeutics for treating inflammatory diseases in HIV-1 patients and for enhancing HIV-1 therapeutic vaccination to achieve HIV cure.